Core B: Engagement

Core B (Engagement) Summary
The specific aims for Core B (Engagement) of the Texas Center for Learning Disabilities (TCLD) are 1)
Dissemination: to establish, maintain, and enhance strategic connections with researchers, clinicians and
educators for the purpose of disseminating findings, informing practice and influencing policy; 2) Data
Sharing: to coordinate intra- and extra-TCLD resource and data sharing; 3) Career Enhancement: to provide
project-embedded, career-enhancing research opportunities to early-career scholars; and 4) Pilot Grants: to
solicit, review, and select applications for pilot studies focusing on early career scholars.Dr. Greg Roberts will
be the Core B Director. He will work closely with Dr. Jack Fletcher as overall PI of the TCLD and Co-PI on
Core B as well as Dr. Sharon Vaughn as overall Co-PI and Co-PI of Core B to address the Core B objectives.
Drs. Roberts, Fletcher, and Vaughn will coordinate with Project PIs and Core Directors (the Executive
Committee) to plan, implement, and evaluate progress towards benchmarks for each of the four aims and the
Core B will continue to operate a website that translates and disseminates
research findings and evidence-based practices relevant to researchers and practitioners. These materials will
include external resources, lesson plans from Project 3 (Intervention), research summaries under Education
Research Matters, and TCLD research findings. Under Aim 2, data sharing plans will be implemented for
investigators working within the center and for interested external investigators. Under Aim 3, early career
researchers at the graduate student, post-doctoral fellow, and junior faculty levels will be embedded across the
Center's program of research to support their developing careers as researchers in learning disabilities. Aim 3
will also provide career-enhancing opportunities to more-senior investigators interested in broadening their
research to include LD-related topics. Under Aim 4, Core B will oversee and evaluate the proposed ancillary
pilot projects
Publication Plan. Under Aim 1,
awarded to LDRC early career researchers and to more-senior investigators who are beginning
programs of research into learning disabilities. Core B will also initiate and manage the required Publication
Plan and facilitate the utilization of technology to foster engagement among other LDRC sites and investigators
and to target dissemination activities.